Mouse Target Assessment Core

DESCRIPTION (provided by applicant): Heavy alcohol drinking and binge drinking are patterns of alcohol consumption considered abusive and which are associated with increased risk of injuries, physical maladies, mental illness, and increased risk of dependence upon alcohol. Once dependent, alcohol abuse becomes chronic;with strong craving, continued use despite physical, psychological and social problems, and loss of control over intake. Excessive drinking is a hallmark of both abuse and dependence. INIA-West has focused on excessive alcohol drinking as a target for animal model development, cellular and molecular investigation, and, ultimately, on medications target identification. While there are currently three FDA approved medications for alcohol dependence available, disulfiram, naltrexone, and acamprosate, there is still a push by NIAAA to identify more efficacious pharmacotherapies to combat the deleterious effects of heavy alcohol consumption and alleviate those effects that lead to continued intake and relapse. The overarching theme of the Mouse Target Assessment Core is to use INIA models of excessive alcohol drinking and the behavioral effects of alcohol to explore targets that have been identified over the past funding periods. The specific goals of the Mouse Target Assessment Core (MTAC) are to: 1) Continue to optimize and extend INIA models of excessive drinking and provide test services and tissues to consortium investigators;2) Identify and test new target compounds based on INIA-West-generated data;2) Improve in vivo testing of potential pharmacotherapeutic targets;3) Work closely with the Rat Target Assessment Core (Kosten) and the Rat Animal Models and Gene Testing Core (Bell) to standardize our target identification in a cross-species manner;4) Work with INIA investigators as targets are identified and with the Steering Committee and Scientific Advisory Board to prioritize them for testing and determine which to pursue further;and 5) Use RNA interference (RNAi) technology and genetically engineered mice to examine target systems for which usable compounds are, as yet, unavailable as well as to confirm and extend positive results. PUBLIC HEALTH RELEVANCE: Excessive alcohol drinking is a major public health problem that has been the focus of research by the Integrative Neurosciences Initiative on Alcoholism (INIA-West) consortium. We now have robust mouse models and a list of potential therapeutic targets based on this work. The goal of the Mouse Target Assessment Core is to explore the effects of manipulating INIA targets in these excessive drinking models.

Public health relevance
Excessive alcohol drinking is a major public health problem that has been the focus of research by the Integrative Neurosciences Initiative on Alcoholism (INIA-West) consortium. We now have robust mouse models and a list of potential therapeutic targets based on this work. The goal of the Mouse Target Assessment Core is to explore the effects of manipulating INIA targets in these excessive drinking models.